Enhancing the translational potential of therapeutic exosomes for ischemic heart disease

Acute myocardial infarction (MI) continues to be a leading cause of morbidity and mortality worldwide. The adult
human heart has minimal capacity for regeneration. Once damaged, cardiomyocytes (CMs) cannot be replaced
efficiently, leading to a decline in heart function and adverse remodeling. Our long-term goal is to develop novel,
clinically translatable therapeutic strategies for systemic administration that protect CMs following ischemia-
reperfusion (I/R) injury to reduce infarct size and improve clinical outcomes. Exosomes have emerged as potent
vectors for delivery of bioactive cargo for the treatment of various diseases including CVD. In large animal models
of I/R injury, exosomes derived from cardiosphere-derived cells (CDCs) promote cardiac repair but require
intramyocardial delivery, limiting their clinical potential. Likewise, while exosomes have demonstrated pre-clinical
efficacy, it is unclear what cargo is necessary to mediate these benefits and how it can be enhanced. To
overcome these limitations, we seek to identify innovative strategies to optimize therapeutic exosome cargo and
improve tissue and cell-specific delivery. In preliminary studies, we determined that microRNA (miR) cargo is
required for the regenerative potential of CDC-exosomes following acute MI. Furthermore, using surface
engineering, we developed CM-targeted CDC-exosomes (CMP-exos) which showed increased cardiac honing,
retention and repair compared with unmodified CDC-exos post-MI. Together, these data support the central
hypothesis that modifying the targeting capabilities and bioactive cargo of therapeutic exosomes will allow for
development of a clinically relevant systemic based therapy with enhanced efficacy in CVD. The objectives of
this proposal are to determine the specific rate-limiting miR cargo that reduces CM apoptosis in I/R, optimize
therapeutic systemic delivery using CMP-exos, and determine if CMP-exos improve efficacy in a large animal
model of I/R. The central hypothesis will be tested by pursuing three specific aims: 1) Define the role of specific
exo miRNA cargo in modulating CM cell death and cardiac function following I/R; 2) Determine the optimal dose
and route of delivery of CMP-exosomes; 3) Determine the effect of targeting CMP-exosomes to CMs on cardiac
function in a pre-clinical model of I/R. We will pursue these aims using an innovative combination of mechanistic
studies to investigate the necessity and sufficiency of specific miRs on CM cell death, novel exosome engineering
strategies with the potential for development of a systemic based strategy, comprehensive pharmacokinetic
studies, and rigorous pre-clinical evaluation in a relevant large animal model of I/R. The proposed research is
significant because it will elucidate the mechanism/s of action of a potential translational therapy and identify
therapeutic targets to reduce CM cell death in pathways operant in I/R. The proximate expected outcome of this
work is an understanding of the functional contribution of specific miR cargo and CM targeting to exo-mediated
cardioprotection. These results will have an immediate and long-term positive impact by defining cardioprotective
miRs operant in I/R and maximizing the translational potential of therapeutic exosomes through miR cargo
loading and surface protein engineering.

Public health relevance
Ischemic heart disease continues to be the leading cause of death and disability in the United States, impacting the lives of millions of Veterans each year. Cardiomyocyte cell death plays a significant role in left ventricular remodeling and cardiac dysfunction following myocardial infarction (MI) and ischemia-reperfusion (I/R). This project seeks to elucidate the mechanism/s of action of a cardioprotective exosome population and identify therapeutic targets to reduce cardiomyocyte cell death in pathways operant in I/R. Furthermore, completion of this project will yield improved strategies to optimize therapeutic exosome delivery in a cell-specific manner to increase efficacy and decrease off-target effects. This would enhance the treatment of Veterans with a wide spectrum of cardiac disease including heart failure and myocardial infarction.